CFAR Network of Integrated Clinical Systems (CNICS)

PROJECT SUMMARY / ABSTRACT
Modern antiretroviral treatments alter the progression of disease, enabling the majority of HIV+ individuals to live
near-normal life spans. Yet, ~ 20% of patients in the US fail to achieve long-term virologic suppression, and even
for those who do, there remains the threat of multiple comorbid complications. The critical questions that arise
are how will clinicians maximize treatment success, assess the sociobehavioral barriers to linkage and persistent
engagement in care, understand the causes of treatment and non-treatment related complications of HIV
disease, and develop interventions that maximize health and well-being of HIV infected persons over many
decades of life. To address these questions, investigators need access to clinical outcomes information that is
tightly linked to biologic specimens and socio-biologic and genetic data to enable translational research. The
CFAR Network of Integrated Clinical Systems (CNICS) project is an established resource that has contributed
substantially to the contemporary HIV research agenda. Established in 2002 and funded as an R24 research
platform in 2006, CNICS is a clinic-based research network that reflects the outcomes of clinical decisions and
management options used in the care of HIV infected individuals at 8 CFAR sites: UAB, U Washington, UCSF,
UCSD, Case Western Reserve, Fenway Health (Brown / Harvard), U North Carolina, and Johns Hopkins. What
makes CNICS unique is the way in which CNICS augments the comprehensive EHR data with a combination of
other resources for research that include patient-reported and patient-centered socio-behavioral data;
adjudication of key clinical events; strategic biological specimen collection; and genetic characterization of the
cohort. The mission of CNICS is to provide access to the specimen and data repository to any investigator who
submits an approved concept proposal. In this fashion, CNICS is a 'peer-reviewed open access' research
platform available to investigators worldwide. The specific aims for this competitive renewal of CNICS leverages
the robust CNICS foundation to accomplish the following: 1: Collect high quality data from a representative
sample of patients; 2: Enable investigators to perform research by providing data and specimens to a diverse
array of scientists worldwide; and 3: Mentor early to mid-career investigators engaged in HIV-focused research
in CNICS.

Public health relevance
PROJECT NARRATIVE AIDS is one of the largest pandemics in history that remarkably, in the 40 years since its first description, the etiologic agent was identified, accurate tests to detect its presence were created, and over 30 novel drugs developed. This has turned a universally fatal disease into a chronic, manageable condition. Owing to the rapid emergence of both the disease and its treatment, many unanswered questions regarding the long-term outcomes of patients remain proving that ongoing research is needed to help answer these questions.